Molecular Mechanisms Underlying TRPM3 Regulation in the Cell Membrane

SUMMARY
Membrane proteins and lipids are organized into signaling domains in the cell membrane that are hundreds of
nanometers in size. These signaling domains are essential for the efficiency and specificity required for cell
signaling. The long-term vision of my research program is to determine the molecular compositions and
structures of these membrane protein signaling complexes and understand how their organization results in their
physiological function. This overall vision will be fulfilled through two independent tasks. One is to determine the
molecular mechanisms underlying individual components in a signaling pathway. The other is to directly study
the complex as a whole to understand how different components are assembled with each other. In the next five
years, my goal is to exercise these two tasks on a specific membrane protein ─ the TRPM3 ion channel. TRPM3
plays a critical role in nociceptor neurons and mediates inflammatory hyperalgesia and pain sensation. The
activity of TRPM3 is tightly regulated by the G protein-coupled receptor (GPCR) signaling pathway. Specifically,
we will determine the structures and activities of individual TRPM3 channels in isolation and in cell membranes
to understand the molecular details governing its transition between closed, open, and desensitized states. We
will also determine the compositions and structures of the TRPM3 signaling complex in the cell membrane to
understand how the organization of lipid and protein molecules contributes to TRPM3 signaling efficacy. We will
use electrophysiological recordings in cells and in reconstituted membranes to isolate the contributions from
individual protein and lipid partners. The results from this proposal will not only advance our molecular
understanding of the TRPM3 function but also contribute to the emerging field of integrative structural biology,
where we study the structure of signaling complexes in the native environment using a multitude of atomistic and
molecular approaches. Our efforts will also lead to the development of new methods to study TRPM3 ion
channels in their native environments that are broadly applicable to other membrane proteins and signaling
pathways.

Public health relevance
PROJECT NARRATIVE The central aim of the proposed project is to determine the molecular mechanisms underlying the activity of ion channel TRPM3 in the cell membrane. We will isolate individual TRPM3 channels and determine the structural and functional transitions between closed, open, and desensitized conformations. We will also directly determine the composition and structure of the TRPM3 signaling complex in the native cell membrane. Our efforts will substantially advance our molecular understanding of the TRPM3 ion channel. Our efforts will also lead to new methods that can be applied to a wide variety of other membrane proteins.